Association of blood-brain barrier breakdown with brain microstructure neuropathology in early Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Background: As cognitive decline is a mounting health concern for our aging population, it is becoming
increasingly important to better characterize the neurobiological changes leading to age-related cognitive
impairment and dementia. Although neuroimaging methods have shown promise at detecting microstructural
brain changes associated with cognitive decline and Alzheimer's disease (AD), there is need for biomarkers
with improved sensitivity to the earliest disease stages, when treatments may be most effective. Emerging
research suggests that blood-brain barrier (BBB) breakdown occurs when cognitive impairments are still mild,
and may precede brain atrophy. Further research is needed to understand how BBB permeability changes
over the course of AD and how it relates to established markers of brain microstructure, morphometry and
molecular pathology.
Preliminary Studies: Our pilot study demonstrated sensitivity of Restriction Spectrum Imaging (RSI) to
microstructural brain changes in Mild Cognitive Impairment (MCI) and early AD. RSI, cognitive function and
CSF amyloid-β were measured in 31 healthy controls (HC), 12 individuals with MCI and 13 with mild AD.
Neurite density (ND), a measure of restricted water diffusion that accounts for crossing fibers, was lower in
several white matter tracts, and gray matter isotropic free water diffusion (IF) was higher for MCI/AD than HC.
ND and IF correlated with episodic memory and with amyloid-β burden.
Proposed Studies: Dynamic contrast-enhanced MRI, RSI, structural MRI, CSF amyloid-β and tau, and
neuropsychological data will be acquired on 15 HC with low genetic risk for AD (APOE4 non-carriers) and 15
individuals with MCI. BBB permeability will be compared between groups and correlated with memory
performance, RSI measures, morphometry and amyloid/tau to test whether BBB breakdown is associated
with microstructural changes, cognitive impairment and established AD biomarkers during prodromal
AD (Aim 1). During the R00 stage, neuroimaging, CSF and cognitive data will be collected on 40 HC with low
genetic risk for AD, 70 HC with elevated genetic risk for AD (APOE4 carriers) and 70 individuals with MCI. All
participants will be clinically and cognitively evaluated 2-3 years after baseline to test the hypothesis that
BBB breakdown and RSI metrics predict cognitive decline and are sensitive to preclinical AD (Aim 2A).
Data from all stages will be combined to model patterns of change in BBB permeability, brain
microstructure and molecular pathology from normal to prodromal AD (Aim 2B). Amyloid PET will be
performed on a subset of participants (31 amyloid-negative HC, 37 amyloid-positive HC, 31 MCI) to test the
hypotheses that BBB breakdown correlates and colocalizes with amyloid deposition, and that the
association between increased BBB permeability and amyloid is greater in APOE4 carriers than non-
carriers (Aim 3).

Public health relevance
PROJECT NARRATIVE With the rapidly growing elderly population, better understanding of the neurobiological changes that lead to cognitive decline is imperative for ensuring maintained quality of life into older age. This project aims to assess how the blood-brain barrier breaks down in the earliest stage of Alzheimer's disease, and how these changes relate to other structural and molecular markers of incipient dementia. By enhancing our knowledge about the brain changes contributing to Alzheimer's disease and aging- related cognitive decline, results from this study could have a profound impact on societal health by improving early disease detection and timely intervention.